Corrective editing to treat phenylketonuria

PROJECT SUMMARY
Phenylketonuria (PKU) is an autosomal recessive disorder caused by mutations in the gene encoding
phenylalanine hydroxylase (PAH), resulting in the accumulation of phenylalanine (Phe) to neurotoxic levels.
Although there are treatment options, ranging from a strict low-Phe diet to an oral medication (sapropterin, a
cofactor of PAH) to an injectable enzyme substitution therapy (pegvaliase), many PKU patients find it challenging
to adhere to the dietary intervention and have limited responses to or access to the medical therapies and, as a
result, have impaired cognitive development and develop a range of neuropsychiatric problems. Durable and,
ideally, curative therapies are needed to address the unmet medical needs of PKU patients.
More than 1,000 PAH variants have been cataloged in patients. These vary in their consequences for PAH
activity, from having little or no effect to eliminating PAH activity completely. Certain variants occur much more
commonly than others in PKU patients. The most frequently occurring pathogenic PAH variant worldwide is the
R408W (c.1222C>T, p.Arg408Trp) variant. Patients homozygous for this variant do not respond to sapropterin,
limiting their treatment options.
In vivo gene editing is an emerging therapeutic approach to making DNA modifications in the body of a patient,
such as in the liver. Gene-editing tools include nucleases, cytosine base editors, adenine base editors, and prime
editors. CRISPR base editors and prime editors are attractive because they can function efficiently for introducing
precise targeted alterations without the need for double-strand breaks, in contrast to CRISPR-Cas9 and other
gene-editing nucleases. We and others have demonstrated the ability of base editors to make specific DNA edits
with very high efficiency and limited off-target effects in the liver in mouse models and non-human primates.
We now seek to assess whether a one-time delivery of adenine base editing or prime editing can be used to
permanently correct the human PAH R408W variant in human hepatocytes in vitro and in the liver in humanized
mice in vivo efficiently and safely and, if so, the optimal editing system to use for this purpose. Success in
completing this translational project will provide critical information on the feasibility of an in vivo genome-
editing approach that could ultimately yield a one-shot, long-term therapy that permanently corrects the most
frequent PAH pathogenic variant and thus serves as a potential cure for PKU patients with this variant. The
proposed work, if successful, could open the door to a new therapeutic modality for many PKU patients—
not just for patients with the PAH R408W variant, but those with other editable pathogenic variants in the PAH
gene—as well as patients with such variants in other liver-expressed, disease-associated genes.

Public health relevance
PROJECT NARRATIVE Phenylketonuria (PKU) is an inherited disorder in which mutations in the phenylalanine hydroxylase (PAH) gene causes a buildup of the amino acid phenylalanine in the body and, as a result, a variety of serious medical problems. The most common PAH mutation identified in PKU patients, the R408W mutation, does not respond to a standard medical therapy. We seek to use two types of CRISPR gene editing technology, called base editing and prime editing, to directly and permanently correct the R408W mutation at the DNA level in the liver, a strategy that could potentially cure a large number of PKU patients.